The impact of bilingualism on cognitive reserve/resilience using socio-demographically and linguistically diverse populations

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most common form of dementia, impacting millions of people globally.
Despite the advancements in understanding fundamental biological constructs of AD and the fact that the global
population of bilinguals has outnumbered monolinguals, our understanding of the impact of bilingualism on
AD/ADRD (AD and related dementias) remains limited. Previous bilingualism studies suggest that the bilingual
experience impacts cognition and AD/ADRD, albeit in varying scale that stems from variabilities in demographic
profiles and prevalence of ADRD risk factors.
The overarching goal of this study is to directly interrogate the neural and sociocultural aspects of bilingualism
across multiple race/ethnic groups, with specific emphasis on deconstructing the links between bilingualism and
AD. To accomplish this, the University of California, San Francisco Alzheimer's Disease Research Center in
California, the National Institute of Mental Health and Neurosciences in India, and the Health and Aging Brain
Study- Health Disparities study in Texas will jointly assemble one of the largest, multicultural, multilingual, and
well-characterized cohort of 2,200 individuals representing the world’s most commonly spoken languages:
Chinese, Spanish, Kannada, and English languages.
This study team will collect cross-sectional data on cognition, imaging, molecular biomarkers, language
background, and SDOH, and follow-up language, SDOH, and cognitive data for three years. We intend to build
a theoretical framework on the cognitive role of bilingualism by deconstructing bilingualism and examining its
features via a multidimensional lens. We will examine the inter-relationship of this multidimensional bilingualism
construct with cognition and social determinants of health using structural and functional magnetic resonance
imaging and AD/ADRD molecular biomarkers. Our central hypothesis is that specific bilingualism features would
influence the cognitive trajectory by improving executive control through the mechanism of brain and cognitive
reserve even after accounting for social determinants of health and AD/ADRD biomarkers.
This proposed study will provide novel mechanistic insights into the multidimensionality of bilingualism and
create an exclusive opportunity to study the cognitive relevance of bilingualism using socio-demographically and
linguistically diverse cohorts. This study also has the unique settings to evaluate the generalizability of the
proposed cognitive-bilingualism theoretical framework across populations that differ in sociocultural,
demographic, and linguistic background.

Public health relevance
PROJECT NARRATIVES This research project focuses on studying the role of bilingualism in cognitive reserve through three socio- demographically and linguistically diverse cohorts: Chinese Americans, Mexican Americans, and Indians. in this project, the University of California, San Francisco, the National Institute of Mental Health and Neuroscience, and the Health and Aging Brain-Health Disparities study joint effort to assemble one of the largest, multicultural, multilingual, and well-characterized cohort of 2,200 individuals to build a theoretical framework for bilingualism and cognitive reserve. The proposed work will enhance our understanding of the multidimensionality of bilingualism and offer valuable insights into the inter-relationships of bilingualism, social determinants of health, and cognitive reserve.